Targeting transducin Beta-like protein 1 in mantle cell lymphoma

Project abstract
This is a K08 career development award proposal from Lapo Alinari, MD, PhD, an Assistant Professor on Tenure
Track in the Division of Hematology at the Ohio State University (OSU). Dr. Alinari will devote a minimum of 75%
of his time to a focused research program on the role of transducin β-like protein 1 (TBL1) in mantle cell
lymphoma (MCL) and related translational research, with the remaining 25% served through 8 weeks of inpatient
service. OSU has an internationally recognized hematologic cancer research program and the Division of
Hematology has an excellent record of training successful physician-scientists. Dr. Alinari has a diverse
mentoring team with a proven track record, including Dr. John C. Byrd (translational science), Dr. Natarajan
Muthusamy (basic science, immunology), and Dr. Kevin Coombes (genomics/bioinformatics) to advise and
support him in his research aims and career development plan. This team will be complemented by an advisory
committee consisting of Dr. Robert A. Baiocchi (translational lymphoma) and Dr. Kristie A. Blum (clinical
lymphoma). Dr. Alinari’s career development plan builds upon his prior research experience and includes
formal coursework to further his knowledge of genomics, bioinformatics, immunology, drug development as well
as professional development activities to enhance networking, improve manuscript/ grant writing skills with
the goal of becoming an independent translational investigator focusing on MCL. MCL is an aggressive subtype
of B-cell NHL which remains incurable. The Wnt/β catenin signaling pathway is aberrantly activated in many
cancers including MCL, and promotes tumor cell survival through modulation of Wnt target genes. Targeting β
catenin has been unsuccessful due to the complexity of its structure and to the many off target effects of the
compounds tested thus far. TBL1 is an E3 ubiquitin ligase that binds to β catenin to promote its transcriptional
activity. The objective of this research project is to functionally characterize the role of TBL1 in MCL, to
validate TBL1 as a novel therapeutic target in preclinical models of this disease, and to study the molecular
mechanism through which tegatrabetan, a small molecule inhibitor of TBL1, induces MCL cell death. The
rationale is that the critical role of TBL1 as a transcriptional modulator is unexplored in MCL. Dr. Alinari’s
preliminary data show that, in contrast to normal immune cells, MCL cells express high nuclear levels of TBL1
and are exquisitely sensitive to TBL1 inhibition, suggesting TBL1 is a potential novel therapeutic target in this
disease. The central hypothesis is that TBL1 promotes the uncontrolled proliferation and survival of MCL cells
through its dual ability to activate transcription of Wnt/β catenin target genes while repressing transcription of
tumor suppressor/regulatory genes and that TBL1 inhibition via tegatrabetan will promote MCL cell death through
modulation of the TBL1 transcriptional program. The work accomplished here will provide data on TBL1 function
in MCL and promote the clinical development of tegatrabetan. Data obtained from these preclinical studies will
be used to apply for additional funding to support a phase I clinical trial with tegatrabetan in MCL patients.

Public health relevance
Project narrative Despite immune-chemotherapy-based approaches, the prognosis of patients with relapsed/refractory mantle cell lymphoma remains poor. The purpose of this grant is to functionally characterize the oncogenic role of a novel molecular target called TBL1 and to develop strategies for its therapeutic targeting that can be taken into the clinic in future clinical trials with the goal of improving outcomes of mantle cell lymphoma patients.